EFFECTS OF DIETARY FATTY ACID COMPOSITION ON ENERGY BALANCE AND BLOOD PRESSURE

Assess the effects of type of dietary fat on blood pressure, determinants of blood pressure, and energy balance in obese, hypertensive subjects during a weight reduction diet.